Translational Nanobiology Approaches to SARS-CoV2

We established and are maintaining an open-access resource at nano.ccr.cancer.gov wherein protocols and methods for virus and EV detection or characterization that is developed in this program are shared with the worldwide research community. Since launch of the website, we have been posting updates on a near-weekly basis. Between January and August 6, 2021, our website, https://nano.ccr.cancer.gov, has had 545 visitors from 41 different countries. During that time period, there were 176 software downloads from 93 unique users.